Biodistribution and circulatory persistence of hyper-compliant microcarriers

Project abstract
The goal of this pilot project is to investigate the vascular persistence of a novel hydrogel microcarrier that mimics
the size of white blood cells but is extremely deformable, which is hypothesized to help avoid entrapment in small
blood vessels and limit engulfment by phagocytic cells. The carriers we developed for this purpose are called
hyper-compliant microparticles (HCMPs). The HCMPs, which can encapsulate other nano/microparticles that
elute drugs or chelate toxins, are expected to circulate throughout the body for days, weeks, or even months just
like native blood cells.
The proposed project will compare the circulatory persistence of “hyper-compliant” versus “stiff” microparticles
(MPs) following tail vein injection in an immunocompetent mouse model. Periodic blood draws will be taken to
perform MP counts via spectrophotometry and microscopy. We will also investigate biodistribution and potential
clearance of the near-infrared fluorescence-labeled MPs following the same administration procedures but with
inclusion of live animal imaging over the course of a week. Animals will then be sacrificed, blood collected, and
organs explanted before completing a secondary analysis of MP distribution via fluorescence imaging and
histology. It is expected that “hyper-compliant” MPs will remain in circulation and be able to pass through even
the smallest capillaries, whereas stiffer MPs will become entrapped in organs like the lung. Vascular persistence
is also expected to be influenced by HCMP evasion of immune cell uptake due to its hydrophilic surface, relatively
large size, and high deformability. We will explore this further through a small in vitro experiment comparing
macrophage uptake of “hyper-compliant” versus “stiff” MPs when left uncoated or opsonized with IgG.
If HCMPs can continue to circulate for even a week, this would have a significant impact for multiple therapeutic
directions. Perhaps foremost would be the sustained release of intravascular drugs, which would greatly benefit
from having a microcarrier technology that prevents drug-eluting nano/microparticles from being filtered out of
the blood or cleared by the mononuclear phagocytic system. Likewise, strategies for toxin removal from blood,
e.g, heavy metals or harmful drug metabolites, would have many new avenues of discovery with a vascular
vehicle that functions as a long-acting sorbent. The current project is necessary before pursuing these exciting
new directions, and while preliminary work is very encouraging, a more rigorous study is needed for completion.

Public health relevance
Project Narrative Injecting therapeutic materials into the bloodstream is the quickest means of delivery to the whole body, but unfortunately, these materials are typically removed within minutes-to-hours by the filtering organs and immune cells. Interestingly, these same cells can circulate in the bloodstream for months in part because of their high deformability, which helps them avoid becoming stuck in small capillaries. This project will investigate whether a novel hydrogel microparticle that is sized similarly to a cell but is even more deformable can be used as a persistent vascular microcarrier, with broad implications for therapies ranging from drug delivery to molecular sensing to toxin scavenging.